Assessing scaphotrapeziotrapezoid arthrokinematics using 4DCT

PROJECT SUMMARY / ABSTRACT
Wrist osteoarthritis (OA) is a prevalent, debilitating condition; however, limited attention has focused on the
scaphotrapeziotrapezoid (STT) joint. The STT is positioned on the radial side of the wrist, spanning both rows
of carpal bones and bridging the thumb and wrist joints. STT OA impacts between 15% and 24% of adults over
45 years of age, with increased prevalence and incidence given advancing age and female sex. However,
compared to hand joints, the STT has received limited diagnostic and therapeutic attention. The wrist is
anatomically complex: the number, unique geometries, small size, and close proximities of carpal bones pose
challenges for diagnostic imaging and guiding evidence-based surgical interventions. Due to intricate carpal
interrelationships, a strong biomechanical foundation of normal STT function during motion and under loading
is critical for tailoring interventions that remedy symptomatic STT OA without compromising the remainder of
the carpus or thumb. Thus, there is a need to understand the complex interplay between carpal bones during
motion in unaffected participants. Specifically, there is a need to measure bone motion dynamically to
understand the relationships between carpal bones during various motions of the wrist and hand under
different loading conditions. 4DCT (3DCT over time) yields a time series of image volumes captured during
motion with high spatial and temporal resolution, offering the exciting capability to capture bones dynamically.
Interosseous proximity distributions, a proxy for pressure, and centers of closest proximity will be used to
describe the joint relationships as a function of motion and loading, conferring an in-depth understanding of the
STT joint in both unaffected and pathological states. Further, the magnitude and variability of joint space and
shape at each STT articulation have not been rigorously quantified. Statistical shape modeling (SSM) and
machine learning of STT carpal bones collected from unaffected and pathological STT joints will allow us to
elucidate the interactions between interacting geometries of articulating surfaces during motion and bone
morphology. Our study aims to understand STT arthrokinematics in normal and pathological conditions in the
following aims. Aim 1: Quantify STT arthrokinematics during unresisted and resisted wrist and thumb motions,
separately, in participants without wrist OA and quantify normal variations in STT morphology. Aim 2: Quantify
STT arthrokinematics during unresisted versus resisted activities in patients with early-stage STT OA using
4DCT and compare 3D morphologies of unaffected and pathologic STT joints. 4DCT data elucidate motions
and loads that stress the joint, while morphologic data indicate sites of structural change. A parallel analysis
will allow us to define structure-function interactions at the STT joint. The Aims will culminate in a
comprehensive view of how STT loading impacts arthrokinematics in participants with and without OA. An
integrative understanding of morphology and the role of load in provocative maneuvers will enhance our
understanding of this complex joint, promoting biomechanically motivated diagnostic and treatment strategies.

Public health relevance
PROJECT NARRATIVE Osteoarthritis of the hand and wrist are common, disabling conditions; however, relatively limited attention has focused on characterizing the bone motion of the thumb base’s scaphotrapeziotrapezoid joint, which bridges the thumb and wrist joints. Our project investigates structure-function interactions at the scaphotrapeziotrapezoid joint by combining (1) dynamic CT imaging-derived joint-level motion during thumb and wrist activities with (2) variations in bone shape as quantified with statistical shape modeling. These findings will advance our understanding of the healthy scaphotrapeziotrapezoid joint as well as mechanical factors associated with wrist osteoarthritis.